Database and Software Tool Development

This contract funding supports website development activities conducted by the National Cancer Institute. Critical open-source infrastructure components that others can use to develop valuable databases and software tools to meet specific research needs. Expanding suite of tools is built from these foundational components.